Substance Use Prevention Track at the Biennial Native Children's Research Exchange (NCRE) Conference 2025

PROJECT SUMMARY/ABSTRACT
Long before NIDA’s Racial Equity Initiative was launched in the summer of 2020, the Native Children’s
Research Exchange (NCRE) was created to be a home for researchers focused on child and adolescent
development within Indigenous communities. NCRE conferences provide opportunities for rapid exchange of
information and foster relationships that are central to effective research in partnership with communities.
Since the first conference in 2008, NCRE has focused on making space for researchers to engage in deep
dialogue about their research with others also working to inform better outcomes for Indigenous children
through rigorous research. Specifically, NCRE has become a focal meeting for researchers and community
partners seeking to grow their understanding of research related to substance use prevention for Indigenous
youth. Over the past 16 years, NCRE has fostered a culture of open dialogue and exchange of ideas that has
resulted in fruitful cross-institutional and interdisciplinary collaboration. This platform has amplified the reach
and impact of the scarce research resources dedicated to Indigenous health research. Many NCRE members
are already directly engaged in developing, testing, and implementing prevention programming for Indigenous
children and adolescents. Others are engaged in research that has implications for substance use prevention
(e.g., research on the impacts of exposure to trauma on children’s developmental outcomes or on the
protective role of culture). With a focused Substance Use Prevention Track within the upcoming 2025 NCRE
conference, leading researchers and emerging investigators will gather to share their latest work, which can
then be leveraged to find innovative strategies to support prevention of early and problematic substance use
among Indigenous youth. We will use the NCRE conference platform to implement a Substance Use
Prevention Track that will: (1) Build Indigenous leadership in youth substance use prevention research, and (2)
Broadly disseminate culturally grounded solutions to Indigenous youth substance use prevention

Public health relevance
PROJECT NARRATIVE Indigenous youth in the United States (American Indian, Alaska Native, Native Hawaiian) are at disproportionate risk for early initiation of substance use and subsequent problematic substance use or disorder. Effective prevention approaches depend on careful attention to culture and place and strategies that fit the needs and contexts in which Indigenous children and families live. The Native Children’s Research Exchange (NCRE) conferences have been a forum for the exchange research findings, establishment of collaborations, and dissemination of innovations since 2008; the Substance Use Prevention Track at the 2025 NCRE Conference will support Indigenous research leadership and elevate culturally-grounded solutions to youth substance use prevention.